NF-kappaB in pathogenesis and therapy of head and neck cancer

As part of The Cancer Genome Atlas group characterizing head and neck cancer, we have identified components of the classical and alternative NF-kB, PI3K-mTOR, and Notch pathways as candidate genetic drivers for aberrant NF-kB activation and defects in death signaling. A clinical trial with PI3K-mTOR inhibitor rapamycin has completed accrual and published. A multi-center trial targeting IAPs in the classical TNF-NF-kB pathway in combination with re-irradiation has been approved and opened. Studies using a genome wide RNAi screen employing NF-kB reporter lines have identified potential drug targets promoting NF-kB activation, under investigation.